Identifying host factors that block engraftment and progression of transmissible cancer as a model of AML

SUMMARY:
Identification of host genes and pathways that can block cancer cell engraftment and growth could lead to
revolutionary new cancer treatment strategies. In metastatic cancer, there are many steps in which cancer cells
interact with the host microenvironment: the release of cells from their original location, travel through the
circulation, engraftment into a distant location, and growth in the new environment. So-called liquid tumors
like acute myeloid leukemia (AML) are not often considered to be metastatic, but leukemic cells disseminate
throughout the body and can lead to solid metastasis-like tumors called myeloid sarcomas, interacting with
the host microenvironment in similar ways. In the soft-shell clam (Mya arenaria), and other bivalves, fatal
AML-like cancer lineages have evolved that metastasize repeatedly—not just from a primary to a secondary
site, but from one whole animal to another, over and over again throughout the population for decades or
longer. These fatal contagious cancers exert a strong selective pressure in nature to select for clams which can
block engraftment and growth of this lineage of cancer cells. We will use this unique bivalve transmissible
neoplasia (BTN) system as a model of AML to determine (1) which microenvironments expression patterns
correlate with metastatic growth, (2) what genes correlate with resistance to progression, and (3) how
different populations have evolved resistance to cancer. This study has the potential to provide an
unprecedented understanding of cancer microenvironment and reveal new and important interactions
between cancers and their hosts.

Public health relevance
NARRATIVE (Public Health Relevance): Acute myeloid leukemia (AML) is a serious disease characterized by massive proliferation of disseminated cancer cells throughout the body, including engraftment into solid tissues. We will investigate the unique bivalve transmissible neoplasia model of AML, in which wild populations of clams appear to have evolved a block to cancer engraftment and growth. By comparing how the host cells interact with cancer in cases in which the cancer survives and in cases in which the host can control and reject the cancer, we will understand new mechanisms for the control of cancer which could lead to completely new strategies to treat cancer.